Interactions of Sex and Gender Factors in Risk for Alzheimers Disease: Links Between Stress, Neural Activity, Inflammation, and Memory

PROJECT SUMMARY/ABSTRACT
Our proposed project focuses on understanding interactive effects of gender and sex on biological processes
implicated in Alzheimer’s disease (AD) risk. Gender is defined as an individual’s presentation as female or male,
and sex is defined by chromosomes and sex organs. Stress has both gender- and sex-linked components.
However, whether exposure to gender-linked stressors relates to neural and peripheral processes that promote
AD pathology, or whether sex hormones mediate these relationships, is unknown. In this proposal, we seek to
understand interactive effects of gender-linked stressor exposure and estrogen levels on memory, memory-
related neural activation, functional connectivity (FC) at rest, and peripheral inflammation. In doing so, the
proposal enables further study of AD mechanisms and development of interventions to reduce AD risk. The
objective of this proposal is to determine interactive effects of lifetime gender-linked stressor exposure and
estrogen levels on memory-related brain activation, resting state FC, peripheral inflammation, and verbal
memory in midlife women at risk for AD due to family history. The rationale for this project is that gender and
sex, indexed by stress exposures and estrogen, interactively promote changes in neural activation, FC, and
peripheral inflammation, which may facilitate AD pathology in women at risk for AD. Specific Aim 1 will investigate
interactive effects of gender-linked stressor exposure and estrogen levels on fMRI activation during memory
encoding, fMRI task performance, and default mode network (DMN) FC at rest. Specific Aim 2 will investigate
effects of gender-linked stressor exposure and estrogen interactivity on peripheral inflammation and verbal
memory. Specific Aim 3 will investigate the effects of peripheral inflammation on fMRI activation and FC at rest.
To achieve these aims, we will recruit participants from our Women’s Alzheimer’s Movement Prevention Center
at Cleveland Clinic, which serves women at risk for AD due to family history. Specific Aims 1-2 will include lifetime
gender-linked stressor exposure as a predictor, and as outcomes, a pattern separation fMRI task, a resting state
scan, plasma levels of pro-inflammatory cytokines, and neuropsychological measures of verbal memory. Specific
Aim 3 will use plasma levels of pro-inflammatory cytokines as predictors of task-based activation and resting
state FC. All analyses will include estradiol levels as a mediator. This study is expected to provide evidence
relating greater lifetime gender-linked stressor exposures to poorer verbal memory in women at risk for AD, as
well as to processes likely to contribute to sex and gender disparities in AD, such as hippocampal hyperactivation
and reduced DMN deactivation during memory encoding, greater posterior to anterior DMN FC at rest, and
higher peripheral inflammation. The proposed research is innovative in its focus on variables impacted by sex
and gender that may catalyze AD pathology in women at risk for AD, and is significant in providing strong
scientific justification for further study of inflammation and neural activity and FC as AD mechanisms. Results of
our study will inform development of interventions targeting stress and inflammation to reduce AD risk.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will allow better understanding of how gender- linked stress exposure and estrogen may interact to impact memory, peripheral inflammation, and neural activation and connectivity in women at risk for Alzheimer’s disease (AD). Knowledge gained from our study will provide a foundation for the further study of stress- and inflammation-based mechanisms of AD and will support the development of cost-effective AD risk reduction approaches for women that may decrease sex-based disparities in AD, which, in turn, should reduce the public health costs of AD. Our research plan aligns with the NIH priority of Advancing Science for the Health of Women, as well as the 2019-2023 Trans-NIH Strategic Plan for Women’s Health Research Strategic Goal 1 objective to identify immediate, mid-, and long-term effects of exposures on health and disease outcomes.